Brain Cholesterol Biosynthesis in Health and Neurological Disease

PROJECT SUMMARY
The objective of this application is to establish a novel framework to support investigations into the role of astrocytes
in neurological disease, including neurodegeneration, as well as vascular contributions to cognitive impairment and
dementia (VCID). The application is motivated by observations linking astrocyte dysfunction to cerebrovascular
disease. We propose to investigate the role of astrocytes in cerebrovascular malformations by systematically dissecting
the functional relevance of CCM3 (Cerebral cavernous malformation 3) in model organisms and primary cultures. Loss-
of-function mutations in CCM3 cause the most aggressive form of familial Cerebral Cavernous Malformations (CCM), a
common cerebrovascular disease of seizures and hemorrhagic stroke characterized by the presence of vascular lesions
(known as CCMs, cavernous angiomas, or cavernomas) in the central nervous system. Our ongoing research in mouse
models suggested that CCM3 has unique and specific functions in astrocytes, in addition to its established role in
vascular endothelial cells. CCM3 deficiency in radial glia progenitors and astrocytes has cell-intrinsic effects, leading to
astrocyte activation and dysfunction. In addition, it has cell non-autonomous effects, and results in generalized
cerebral vascular pathology and formation of CCM-like lesions in mice. The proposed studies take advantage of animal
models we generated, as well as primary cultures of astrocytes, aiming to investigate the consequences of CCM3
deficiency in astrocytes at the structural and molecular level, with attention to astrocyte reactivity and cholesterol
production, both of which have been linked to other neurological and neurodegenerative disorders. By elucidating cell
intrinsic functions of CCM3 in astrocytes and defining the molecular cascade that mediates its actions, we aim to
understand how astrocyte dysfunction contributes to pathology. Our studies carry basic biological value and, by
extending mechanistic understanding of CCM3 action, will allow us to gain what may be therapeutically important
insights into CCM disease. Moreover, our findings have the potential to establish a genetically tractable system in
which to investigate reactive astrocyte dysfunction not only in CCM, but in other neurological diseases, including VCID
and neurodegeneration.

Public health relevance
PROJECT NARRATIVE The proposed work seeks to develop a novel framework to connect cerebrovascular disease with neurological disorders, including neurodegeneration. The proposed work is inspited by findings in Cerebral Cavernous Malformations (CCM), a condition characterized by the presence of vascular malformations in the brain, which can cause focal neurological problems, seizures, and hemorrhagic stroke. Although sporadic forms of the disease are common, hereditary (“familial”) forms of CCM also occur. CCM3 is one of the causative genes of familial CCM disease, and when not functioning properly, it causes an aggressive form of the disease, with severe symptoms that start in childhood, and is associated with cognitive impairment in adult patients. Understanding the role this protein has on the development of the brain using model organisms and cultured cells is the goal of the proposed work. The work is motivated by our findings of dysfunctional astrocytes, an abundant cell type in the brain that is known to contribute to neurological and neurodegenerative disease, in CCM disease models. With the proposed work, we aim provide insights into the biology of the CCM3 protein, the pathogenesis of CCM, and establish astrocyte dysfunction and changes in astrocyte physiology leading to dysregulation of cholesterol homeostasis as an entry point to other neurological, as well as neurodegenerative, disorders.